Spatial and Tensor Methods for Estimating the Health Effects of PFAS Mixtures

PROJECT SUMMARY
Perfluoroalkyl and Polyfluoroalkyl Substances (PFAS) are synthetic compounds found in the environment and
linked to adverse health outcomes. However, understanding the causal effects of PFAS mixtures on various
health outcomes remains limited. This project addresses this critical knowledge gap by employing innovative
spatial and high-dimensional causal inference methods to enhance our understanding of PFAS health effects. By
bringing scientific rigor to observational studies, the project aims to overcome the challenges posed by spatial
dependence, various sources of bias, and high dimensionality in PFAS studies.
This project leverages two valuable health outcomes data sources relating PFAS in drinking water: (i) a nationwide
cohort of Medicare beneficiary data and (ii) a North Carolina electronic health records cohort. These cohorts have
been linked to PFAS concentrations in the ground water sources and in the tap water used for drinking. These
data of health outcomes contain individual-level information and provide comprehensive resources for enhancing
the understanding the effects of PFAS on population health. Based on previous epidemiological analysis of
associations with PFAS exposure in the two cohorts we have identified three statistical challenges. First, spatially-
dependent outcomes violate standard assumptions of causal inference, necessitating a rethinking of the potential
outcomes framework. Second, various sources of bias are present such as preferential sampling and non-
random actualization of PFAS exposures. Third, the high dimensionality of the PFAS chemical mixture and
health responses introduces computational and stability issues, requiring new dimension-reduction methods. By
developing a suite of methods tailored to address these challenges, this project marks a significant advancement
in the field of epidemiological research. The proposed methods will enable accurate estimation of causal health
effects in observational spatial studies, providing refined insights into the impact of PFAS mixtures on a range of
health outcomes.
To tackle these challenges, the project outlines three specific aims. Aim 1 focuses on developing spatial causal
inference methods for preferentially-sampled data, accounting for bias in sample-location selection. Aim 2 devel-
ops spatial causal inference methods for multiple outcomes and exposures that use tensor regression model to
explain variation in the health effects by exposure, response, and spatial resolution. Aim 3 develops a structured
statistical protocol for spatial causal inference analysis of multiple exposures and outcomes, with application to
health effects of PFAS at the state and national levels. These aims not only address the specific challenges in
PFAS studies but also have broader implications for epidemiological research dealing with spatial dependence
and high-dimensional data. Through the development of these innovative methods, this project aims to transform
the analysis of PFAS studies, contributing to advancements in the field and improving our understanding of the
health effects of PFAS exposure.

Public health relevance
PROJECT NARRATIVE PFAS “forever” chemicals are pervasive in the US and have been associated with adverse health outcomes including hypertension, liver and thyroid diseases, and some types of cancer. Precisely quantifying the effects of these chemicals is challenging because the data are typically observational, spatially-dependent and high- dimensional. We develop new causal inference methods and apply them to PFAS data in California, North Carolina and across the US to refine our understanding of this emerging public health risk.